Administrative Core

Administrative Core
The objective of the Administrative Core is to link together the various elements of the Weill Cornell
Medicine Contraception Research Center (WCM-CRC). This center, titled “On-demand nonhormonal male
contraception via ADCY10 inhibition,” has a singular scientific theme; to identify the safest and most
efficacious means for blocking soluble adenylyl cyclase (sAC; ADCY10) in vivo to achieve an on-demand
contraceptive pill for men. To achieve this goal, the WCM-CRC leverages the established inter-disciplinary
team comprised of expertise in sAC physiology, pharmacology, biochemistry, reproductive biology,
structural biology, enzymology, computational modeling, medicinal chemistry, and drug development. This
team, which has been effectively and efficiently working together for the past 4 years, successfully
advanced sAC inhibitors into potent, specific, drug-like leads that demonstrated proof-of-concept for on-
demand male contraception in vivo in mice. This administrative core mirrors the successful administrative
core from the previously funded WCM-CRC; all personnel and operational resources are maintained. Due
to the advancements made over the past four years, the WCM-CRC investigative team joined forces with
an expert in reproductive biology and an expert in contraceptive marketing and end-user preferences to
form Sacyl Pharmaceuticals, Inc. (SACYL), a biotech company established to further develop and market
sAC inhibitors as nonhormonal, on-demand birth control pills for men. SACYL will provide `Pharma-quality'
drug development expertise to augment the work proposed in this application. In addition to ensuring that
the established group of collaborators comprising the WCM-CRC functions as a single entity, the WCM-
CRC Administrative Core will be responsible for maintaining complementarity between the WCM-CRC and
SACYL as well as fostering interactions between the WCM-CRC and NICHD program personnel,
investigators in other CRCs, and regulatory agencies. The Core's administrative responsibilities include
planning, flow of information, developing resources, outreach, and overall administration for the WCM-
CRC. In practice, the WCM-CRC Administrative Core will provide structure and oversight for the already
existing relationships between the two co-Principal Investigators, the other project leaders, SACYL, and
the Center's advisory committees.